The Transition from Childhood into Adulthood among PSID Children, 2025

Project Summary/Abstract
This project will continue and enhance the collection and distribution of data on young adults in families partici-
pating in the Panel Study of Income Dynamics (PSID). PSID is a longitudinal survey of a nationally representa-
tive sample of U.S. families that began in 1968. As of 2024, it has collected data on the same families and their
descendants for 43 waves over 57 years. In the 1990s, PSID began collecting rich and detailed data on chil-
dren born into these families as part of the original PSID Child Development Supplement (CDS) and, starting in
the mid-2000s, has closely followed these children’s transition across the young adult years through the bien-
nial PSID Transition into Adulthood Supplement (TAS). Young adults in PSID families become members of the
Core PSID themselves and receive the full biennial interview when they form their own economically independ-
ent households—and are followed by the study for the rest of their lives. In order to continue capturing the tran-
sition into adulthood for all PSID children, this project will conduct a new wave of TAS in 2025. A major portion
of the TAS sample in 2025 will comprise of young adults who previously participated in CDS, which began as a
cohort study but now is conducted on all children aged 0–17 years in PSID families every five years, with two
waves completed (CDS-2014 and CDS-2019) and another wave currently underway (CDS-2024). TAS in 2025
will also include many respondents who have participated in one or more prior waves of TAS, allowing us to
continue tracing their transition into adulthood. The specific aims are to collect the 2025 wave of Transition into
Adulthood Supplement from all PSID youth aged 18–28 years and to document and distribute these data
through the publicly available and free PSID Online Data Center. We will collect new information to capture
how the Dobbs decision and shifting pattern of state-level reproductive policy affects key outcomes related to
contraceptive use, sexual behavior, and fertility. We will also collect new retrospective content on childhood
circumstances and exposures. We will build upon the successful adoption of a mixed-mode design using inter-
net interviewing as well as computer-assisted telephone interviewing. Interviews will be conducted with approx-
imately 2,865 young adults. These data are vital for our understanding of the contemporary transition from ado-
lescence into adulthood in the U.S. within its intergenerational family context. By augmenting the panel infor-
mation in the CDS and Core PSID, this project will provide a rich, integrated CDS-TAS-PSID panel of children
from birth and preschool through primary and secondary school and then through entry into the world of work
or of higher education in conjunction with early family formation. Although a full and detailed panel from birth to
young adulthood is valuable in its own right, the information on these individuals will grow further as they con-
tinue in Core PSID for the rest of their lives.

Public health relevance
Project Narrative This project will continue and expand the collection of data on young adults in families participating in the Panel Study of Income Dynamics (PSID) by conducting a new wave of the PSID Transition into Adulthood Supplement (TAS) in 2025 and by documenting and distributing these data. The continuation of TAS data collection is vital for enhancing our understanding of the contemporary transition from childhood and adolescence into adulthood in the U.S. within the current policy and intergenerational family context.